Specificity, Phenotype and Function of Pancreatic CD8 T Cells in Human Type 1 Diabetes

Title: Specificity, Phenotype and Function of Pancreatic CD8 T Cells in Human Type 1 Diabetes
Project Summary
Human type 1 diabetes (T1D) is characterized by the immune-mediated destruction of insulin-producing pan-
creatic beta cells. CD8 T cells are the most common cell found in insulitis lesions and are the principal T cell
type implicated in beta cell destruction. Insulin and its precursors have been identified as key autoantigens in
humans and mice due to their local abundance. The previous funding cycles for this grant have enabled us to
lead the field of human islet cell investigation in T1D. Using samples from the national pancreatic organ donor
consortium (nPOD) we have detected, precisely quantified, and identified the exact location of autoreactive
pre-proinsulin (PPI) specific CD8 lymphocytes within the pancreata of human donors. Studies performed within
this project have already revealed significant and novel findings. We first identified auto-reactive CD8 T cells
in the islets of patients with T1D using a specially designed method of tetramer staining. We found that their
frequency is high and likely the most predominant autoreactive cell type (1), a finding which has been inde-
pendently confirmed with other methods by Nakayama et al. (2). More recently (3) we defined the precise
location of these cells within a pseudo-timeline of disease development and concluded that PPI cytotoxic T
lymphocytes (CTL) are already present in healthy pancreata and appear to become 'attracted' to islets during
the development of T1D. This seminal observation indicates that the islets appear to expose themselves to
immune recognition, and thus become a key culprit in driving T1D development. A new key development of
this grant is the Orion (Rarecyte) technology that allows for highly multiplexed studies in whole tissue sec-
tions, combined with state-of-the-art analysis software. The study of the whole section and multiple targets
simultaneously allows to define the islet/immune interface and the communication between PPI CTL and other
immune cells more precisely and with a much reduced number of samples. The present proposal will define
the precise location and function of these interactions, and corroborate these findings in highly innova-
tive human islet microtissues and living donor pancreatic tissue slices using dynamic in vitro models.
Finally, this proposal will decipher mechanistically how some aspects of the islet immune interface can be
reset/restored by the action of GLP1 agonists, building on our recent work which has shown that this drug
class can maintain beta cell function (glucose-induced insulin secretion) in vitro and in vivo during the devel-
opment of T1D (4). Overall, our findings should give us an unprecedented and unique understanding of how
and why T1D develops, and provide mechanistic information using our novel in vitro systems, thus ultimately
aiding the development of new therapeutic options.

Public health relevance
Project Narrative Insulin-producing beta cells can be destroyed by CD8 T cells that recognize self-antigens. We have shown that these cells can be found in high numbers in the pancreatic islets of human donors with diabetes, and we have systematically analyzed antigen-specific CD8 T cells in the endocrine and exocrine pancreas. In the present proposal we will precisely delineate the phenotype, function, and location of antigen specific CD8 T cells and use the state-of-the-art multiplexing tool (Orion) and state-of-the-art machine learning analysis to deter- mine their precise spatial distribution within the whole pancreatic section, and to uncover complex cellular interactions and mechanisms. We will corroborate these findings in highly innovative dynamic in vitro mod- els using human islet microtissues and living donor tissue slices, and finally we will investigate the mech- anisms by which some aspects of the islet immune interface can be restored by the action of GLP1 ago- nists.